Core A: Administrative Core

PROJECT SUMMARY/ABSTRACT - ADMINISTRATIVE CORE (CORE A) The Administrative Core will provide scientific and administrative leadership, vision, direction, coordination, integration, management, oversight, resource-sharing and collaborative mandates, support, and accountability for the Arizona Alzheimer's Disease Research Center (ADRC). It will also provide the scientific leadership and hub for more than 150 researchers from twelve participating organizations in the Arizona Alzheimer's Consortium (AAC), making it possible to dramatically augment and optimize the utilization of our shared resources, support a wide range of researcher studies, develop new research and clinical programs and the next generation of AD and related dementia (ADRD) researchers, and further develop our statewide model of collaboration in AD research. It will permit our ADRC Cores, organizationally supported Affiliated Brain and Body Donation Program (BBDP), Affiliated APOE Program, and pending NIA grant-supported APOE4/APOE2 Allelic Dose Cohort to provide a shared resource of annual NACC- and NCRAD-shared data and samples from about 1,650 research participants per year, including about 100 participants per year who donate their brains and have comprehensive neuropathological assessments after they die, and support our overarching theme: “blood-based biomarkers (BBBs) in the diagnosis, preclinical study and prevention of AD.” It will capitalize on longstanding relationships with our Cores, REC, Affiliated Programs, researchers, clinicians, and organizational and state leaders, a strong record of close working relationships and success, a shared commitment to the prevention of AD, and the proposed ADRC's very existence to help secure and leverage major state, organization and philanthropic investments, maximize the ADRC's impact, fulfill its ambitious and aggressively collaborative goals, and continue to make the fight against ADRD a top priority in Arizona. It will work closely with NIA, NACC, NCRAD, other ADRCs and research programs, and a wide range of other organizations and stakeholder groups, partner with two Resource Centers for Minority Aging Research (RCMARs), our Cores and REC to help develop ADRD-related Native American and Hispanic/Latino researchers, research participant enrollment, and studies. It will administer the ADRC's program for the solicitation, competitive evaluation, and support of four NIA-sponsored 24-month Developmental Projects and ten state-supported 12-month Pilot Projects during the funding period. It will capitalize on ADRC, Gates Ventures and organizational funds to help establish an invaluable resource of NACC and NCRAD-shared data and biological samples for the validation of emerging BBBs in brain donation program participants and underrepresented minority groups and support their potentially transformational roles in AD research drug development, research and clinical care, increase the opportunity for our researchers, colleagues and collaborators to find and support the availability and affordability of an AD prevention therapy in 2025, and help fulfill the goals of the National Alzheimer's Project Act (NAPA).